High Speed, High Resolution Slide Scanner for Research in Translational Medicine

PROJECT SUMMARY/ABSTRACT
This application is an instrumentation grant from the Analytical Imaging Facility (AIF) at the Albert Einstein
College of Medicine to acquire a fully automated, high-capacity, high-resolution slide scanner that can
accommodate both brightfield and fluorescence imaging. The AIF of the Albert Einstein College of Medicine
supports NIH-funded investigators by giving them access to state-of-the-art microscopy technologies that
enhance collaborative, multidisciplinary research. Acquisition of this instrument will have a high impact on the
biomedical research at Einstein and will expand the scope of NIH-funded projects at Einstein. Several projects
have been identified that will heavily utilize the scanner. These include: the study of the formation of invasion
promoting structures used to systemically disseminate metastatic cancer cells in carcinoma (Condeelis),
correlative Intravital-Histopathologic Imaging to dissect the tumor microenvironment (Entenberg), establishment
and validation of an immunocompromised radiation proctitis mouse model (Guha), studying the prometastatic
effects of neoadjuvant chemotherapy in breast cancer (Karagiannis), investigating the effect of tumor
environment on metastasis (Oktay), the analysis of molecular markers of risk of subsequent invasive breast
cancer in women with ductal carcinoma in situ (Rohan), and the study of hepatocyte heterogeneity with respect
to gene transcription signatures and their zonal distribution within the intact liver in healthy tissue as well as
diseased patient tissue (Singer).There are also additional projects of Minor Users and many users in the Einstein
community are anticipated. All of the projects in this application are in need of high-capacity and high-
reproducibility scanning so that analyses may be applied to larger tissues, covering hundreds of fields of view,
rather than the single fields of view acquired on a standard microscope.

Public health relevance
PROJECT NARRATIVE This proposal seeks to acquire a new, state of the art high-speed/resolution whole slide scanner. This instrument will enable researchers to scan whole tissue sections on slides at high resolution to identify routine cell markers as well as rare subcellular structures across large tissue areas. The dual mode (fluorescence and brightfield) allows for flexibility in marker visualization and the high throughput capacity allows for rapid image acquisition on a large number of whole slides, which is needed for large-scale pathological and cancer biology studies providing a profound positive impact on a wide range of public health areas.